Pediatric Endocrinology Training Program

The fellowship in Pediatric Endocrinology is a three-year ACGME-accredited program providing comprehensive training in clinical patient management and guidance in the development of research skills. The fellowship is based at the Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD) at the National Institutes of Health (NIH) Clinical Center, in Bethesda, Maryland (NIH-CC). The NIH Clinical Center supports pediatric endocrine related clinical care and research protocols investigating a wide array of diseases and conditions, including adrenal and pituitary tumors, congenital adrenal hyperplasia, precocious puberty, idiopathic juvenile osteoporosis, Cushings syndrome, obesity, and many others. During the first year of fellowship, the focus is on acquisition of clinical skills. In addition to receiving clinical training at the NIH, fellows rotate at participating institutions including the Children's National Health System (CNHS), Walter Reed National Military Medical Center, and Johns Hopkins University (JHU). This ensures that our fellows are exposed to and familiar with common as well as rare pediatric endocrine conditions, such as diabetes, abnormalities of pubertal development and growth, bone disorders, neuroendocrine tumors, disorders of lipid metabolism, inborn errors of metabolism, etc. Fellows also cover the pediatric endocrine consult service, and take care of outpatients in their weekly continuity clinic. The second and third year are focused on clinical, translational and/or basic research. More information about the NICHD fellowship program is at the NIH training site: http://www.training.nih.gov/